Carolina Center on Alzheimer's Disease and Minority Research (CCADMR)

OVERALL SECTION
PROJECT SUMMARY/ABSTRACT
Due to its tremendous human and financial burden, Alzheimer’s disease and related dementias
(ADRD) have risen to the forefront of the United States (U.S.) public health agenda. Older
African Americans are at an increased likelihood of having ADRD. South Carolina has the
highest age-adjusted death rate from ADRD in the U.S. A better understanding of the role that
sociocultural, behavioral, and environmental determinants have on ADRD outcomes among
African-American communities in the Southeast is critically and immediately needed. The
overall goal of the proposed Carolina Center on Alzheimer’s Disease and Minority Research
(CCADMR) is to increase the diversity of the research workforce focused on population health
and determinants of ADRD disparities through sustained infrastructure that will support
underrepresented and minority (URM) faculty focused on the health and well-being of minority
elders. The Specific Aims of the proposed AD-RCMAR are to: (1) increase the capacity of URM
scholars to advance the science on the sociocultural, behavioral, and environmental factors that
influence ADRD outcomes in order to reduce ADRD-related disparities, with a focus on African
Americans, and (2) advance the science of ADRD research focused on population health and
determinants of ADRD disparities through research education in population-based, secondary
data analysis, interdisciplinary co-mentoring teams, well-established strategies for recruitment of
AD-RCMAR Scientists, and education on Health Disparities and Minority Aging Research. The
proposed CCADMR is a state-wide collaboration, providing mentorship and education on
determinants of ADRD disparities using population-based datasets for URM faculty throughout
South Carolina, at the three major research institutions, including University of South Carolina
(UofSC), Medical University of South Carolina (MUSC), and Clemson University (CU), and three
Historically Black Colleges and Universities (HBCUs), including Allen University, Claflin
University, and South Carolina State University. Interdisciplinary and partner-engaged research,
with which the principal investigators (PIs) and research team have expertise, will be an
effective strategy for addressing ADRD-related disparities. The proposed Center leverages the
multiple PIs’ extensive leadership in providing critical training in aging and ADRD for URM
Scientists and their research expertise in cognitive aging, minority health, and ADRD disparities.
The PIs and Core Leads are well-established and collaborative scholars with substantial
mentoring experience and content knowledge that will contribute to the success of the proposed
CCADMR.

Public health relevance
OVERALL SECTION PROJECT NARRATIVE South Carolina has the highest age-adjusted death rate from Alzheimer’s disease and related dementias (ADRD) in the United States and older African Americans in South Carolina are at an increased likelihood of having ADRD. A better understanding of the role that sociocultural, behavioral, and environmental determinants have on ADRD outcomes among African-American communities in the Southeast is critically and immediately needed. The overall goal of the proposed Carolina Center on Alzheimer’s Disease and Minority Research (CCADMR) is to increase the capacity and diversity of the research workforce focused on population health and determinants of ADRD disparities through sustained infrastructure that will support underrepresented and minority (URM) faculty.